Characterizing Metals and PFAS leaching from Tampons and their Adverse Effects on a Human Vaginal Mucosa Cell Model

Project Summary
More than 300 million people worldwide menstruate every day. However, the health of menstruators has been
largely overlooked in medical research, health care, and policy but access to safe menstrual products is para-
mount. Due to their effectivess and convenience, up to 86% of menstruators in the United States use tampons.
Unlike other menstrual products, tampons absorb and retain menstrual fluid in the vagina. Tampons come into
direct contact with the vaginal mucosa which has a large surface area and is highly permeable. This unique
properties makes the vaginal absorption of chemicals 10-80 times more efficient than the oral route. Our research
group conducted the first study of metals in tampons and found measurable concentrations of 16 metals in
tampons; 12 metals were detected in all the tampons we tested and also found PFAS in the absorbent material
of tampons. This resulted in the Chair of the Senate Appropriates Committee requesting the US Food and Drug
Administration (FDA) to evaluate whether any steps were needed to ensure tampon safety. This is crucial as
metals and PFAS are known endocrine disruptors, and some have been identified as carcinogens. However,
there are almost o data available about toxicants in tampons, their bioavailaibility and adsorption through the
vagina and the potential effect on vaginal cells. To address these data gaps, the goal of this proposed project is
to characterize for the first time the leaching of metals and PFAS from tampons, as well as to investigate the
vaginal absorption of metals and PFAS and their adverse effects on vaginal cell function and viability. We will
investigate the leaching of metals and PFAS from tampons through in vitro bioelution studies, using a range of
tampons from different brands and adsorbencies to simulate real-life exposure scenarios. These experiments
will assess the release of metals and PFAS under conditions mimicking typical tampon use, using simulated
vaginal and menstrual fluids. Furthermote, using a 3D vaginal mucosa model, we will study the absorption of
metals and PFAS by vaginal epithelium cells and their penetration into the underlying tissue, focusing on their
systemic absorption and toxicity. We will evaluate the direct effects of metal and PFAS exposure on vaginal cell
structure and function, using immunofluorescence and viability assays to measure cellular changes, immune
response, and reproductive markers. These experiments will provide insight into the potential gynecological and
reproductive health risks associated with metal and PFAS exposure. Our study will provide essential data on
exposure risks, vaginal toxicity, and regulatory standards, supporting efforts by the International Organization
for Standardization (ISO) to establish global safety standards for menstrual products by 2027.

Public health relevance
Narrative. Millions of people who menstruate use tampons, but the potential health risks from exposure to chem- icals in these products have not been fully examined. Tampons can contain metals and PFAS, which may disrupt hormones and raise the risk of cancer or infertility. This study will explore how these harmful substances are absorbed through the vagina, which is more porous than skin, to help establish safer standards for menstrual products and protect people’s health.